Environmental Genomics

PUBLIC HEALTH RELAVENCE The next generation of investigators in environmental health will need broad multidisciplinary training. We aim to provide pre- and post-doctoral trainees with training in environmental, genetic, and molecular epidemiology, biostatistics, and bioinformatics to become leading investigators investigating the complex pathways that lead from environmental exposures to disease in human populations.

Public health relevance
PROJECT NARRATIVE This is a renewal of our T-32 training grant in “Environmental Genomics,” aimed at providing multidisciplinary education and research training for five predoctoral and three postdoctoral trainees. For PhD candidates, our program involves a rigorous program of course work based on our existing PhD degree programs in Epidemiology, Molecular Epidemiology, Statistical Genetics & Genetic Epidemiology, and Biostatistics, with a well defined set of core knowledge aimed a bridging these various fields. At the post-doctoral level, the emphasis is on research experience within one of the leading research departments in the country, with extensive portfolios of grant support in environmental epidemiology, genetics, biostatistics, and bioinformatics and superb faculty for mentorship. Our goal is to position our trainees for leadership positions in this rapidly evolving field, by bringing together expertise in field studies, molecular techniques, and statistical and bioinformatic tools.